Calcium signaling in Mycobacterium tuberculosis

ABSTRACT
Calcium (Ca2+) is a major signaling mechanism in eukaryotic cells, but although Ca2+ signaling has ancient
origins, it is not well understood in bacteria. Several bacteria have been shown to maintain a low intracellular
Ca2+ concentration, which is the basis for Ca2+ signaling in eukaryotes. In addition, some bacterial Ca2+-
binding proteins and putative transporters have been identified, suggesting the presence of a bacterial Ca2+
signaling system analogous to that in eukaryotes. However, many fundamental questions about bacterial Ca2+
signaling remain, from maintenance of Ca2+ gradients to Ca2+ triggers, Ca2+ binding proteins, Ca2+ storage,
and finally the effects of changing Ca2+ concentrations on bacterial physiology and pathogenesis. Using a
FRET-based Ca2+ reporter system in Mycobacterium tuberculosis (Mtb) that allows for precise, real time
measuring of intracellular Ca2+ levels, we will explore these fundamental questions about Ca2+ signaling in
Mtb. We will use a novel proteomic approach, thermal protein profiling, to globally detect Ca2+ binding proteins
in Mtb. We also identified a novel Ca2+ porin and will use a porin knockout strain to test for the role of Ca2+ in
Mtb pathogenesis. Together, we will leverage these new tools to test the hypothesis that Mtb maintains a Ca2+
signaling system analogous to that in many eukaryotes and will begin to dissect the physiologic and
pathogenic implications of Ca2+ homeostasis in Mtb.

Public health relevance
PROJECT NARRATIVE Bacteria communicate through different signal transduction mechanisms, one of the least well understood of which is signaling through calcium ions. Here, we will begin to identify the components and roles of calcium signaling in the important human pathogen Mycobacterium tuberculosis.